Translational quality control by trans-editing domains

Summary
Aminoacyl-tRNA synthetases (ARSs) establish the rules of the genetic code, whereby each amino acid is
attached to a cognate tRNA. Errors in this process lead to mistranslation, which can be toxic to cells. Recent
studies suggest that the selective forces exerted by cell-specific requirements and environmental conditions
potentially shape quality control mechanisms. Approximately half of the ARSs possess a proofreading (or editing)
function to hydrolyze mischarged aa-tRNAs and evidence that non-proteinaceous amino acids pose the greatest
threat to fidelity is beginning to emerge. Early work in the Musier-Forsyth lab in the field of translational quality
control focused on our discovery of Class II prolyl-tRNA synthetase (ProRS) editing. This led to a detailed
mechanistic understanding of the novel bacterial ProRS posttransfer editing domain (INS) and the demonstration
that the INS domain, when purified on its own outside the context of the ARS, was fully functional in tRNA
deacylation. We subsequently discovered that single-domain INS homologs are widespread in Bacteria and in
recent years, our focus in this area has turned almost entirely to understanding the function of these INS-like
domains in tRNA editing. However, many open questions regarding the physiological function of these putative
trans-editing proteins remain. The overarching goal of the research described in this MIRA application is to
uncover the specific functions of a growing family of trans-editing proteins known as the INS superfamily. This
diverse yet universally conserved family now has a solid and accumulating in vitro structure-function knowledge
base, which strongly supports a role in maintaining translational fidelity. Our knowledge of the broader
physiological roles of these proteins, especially in eukaryotes, is still in its infancy and is just beginning to reveal
wider roles than previously anticipated. This major gap will be addressed in this work. While classical knock-
down screens that only define essential versus non-essential genes do not immediately identify editing domains
as essential, the strong conservation of these domains implies they play important, and in most cases still
undiscovered, roles in cell survival and competitiveness. Proposed studies are designed to address some of the
many open questions with regard to both physiological trans-editing functions and potential moonlighting
functions of the INS superfamily. These domains are largely unexplored in eukaryotes, including a novel sub-
family cluster that is encoded in many unicellular eukaryotic pathogens. The therapeutic potential of trans-editing
domains has not been exploited and represents another major gap in the field that we hope to address by our
planned studies. In the long term, combining drugs that target novel translational fidelity mechanisms along with
known ribosome-targeting protein synthesis inhibitors such as aminoglycosides, may results in more effective
therapeutic strategies.

Public health relevance
Project Narrative This MIRA application seeks to uncover the specific functions of a growing family of trans-editing proteins that play a universal role in maintaining the fidelity of protein synthesis. Our knowledge of the broader physiological functions of these proteins, especially in eukaryotes, will be addressed in this work. The therapeutic potential of trans-editing domains has not been exploited and represents another major gap in the field that we hope to address by our planned studies.